A versatile lens architecture to shape visible light

PROJECT SUMMARY
This proposal aims to demonstrate a versatile lens architecture to shape light incident on the cornea in order to remedy
deuteranomaly, with potential for other vision disorders. Twelve million people in the U.S. are deficient in their ability to
discern color differences. This negatively impacts their quality of life for health, emotions, and especially careers. They
often have difficulty preparing food, driving, or taking medications. They may be disadvantaged or restricted from certain
work in military, aviation, or engineering. While typically inherited, color vision deficiency (CVD) frequently accompanies
glaucoma, macular degeneration, Alzheimer’s disease, Parkinson’s disease, and other diseases. Color vision deteriorates
markedly with age.
There are wide variations in classification of CVD and its severity. So, outcomes from accommodation by standard tinted
lenses vary considerably. Many such lenses are bandpass filters. They reduce light incident on the retina across a broad
spectral region on either side of the anomaly. This distorts the wearer’s perception of contrast, hue, and intensity. Benefits
of monocular bandpass filters are offset by alterations in depth and motion perception. In contrast, an ideal notch filter
eliminates transmission across just tens of nanometers (nm) of visible light. This separates peak sensitivities of red and
green photopigments which overlap excessively in deuteranomaly. Attempts, however, to make notch filters from dye- or
nanoparticle-doped lenses still produce broad reductions in transmission around the target wavelength. This wavelength is
approximately 560 nm for red-green color blindness. So, doped filters alter perceived hue, saturation, and brightness relative
to normal.
Nature offers clues to high-acuity, red-green color vision in the eyes of the elephantnose fish (Gnathonemus petersii).
Multilayers of submicron-sized crystal lamellae reflect incident light away from rod photoreceptors. Reflection is
wavelength- specific due to submicron spacing between adjacent lamellae. We hypothesize that submicron-spaced optical
nodes at the convex surface of a lens can be customized to sharply reduce transmission at a wavelength near 560 nanometers
Doing so could improve red-green perception based on the anomaloscopic examination of each person. This proposal would
use the PI’s rapid bridging simulations to identify composition, geometry, and spatial arrangement of optical nodes required
to improve color perception based on chromaticity. Specified nodes would be synthesized and self-assembled into a
template stamped with regularly-spaced cavities with few missing nodes. This uses a method recently demonstrated by the
PI. This protolens would be located at the convex surface of a contact lens to integrate into existing contact lens manufacture.
Microspectroscopy of the lens-integrated protolens would quantify improvement in color perception.
This AREA proposal will recruit 8 diverse undergraduates to collaborate with experts in devices, optoelectronics,
simulation, and soft materials to conduct biomedical research that strengthens the research environment at USU and prepares
them to lead independent research in future eye health through mentoring, publication, and proposal preparation.

Public health relevance
PROJECT NARRATIVE This proposal aims to demonstrate a versatile lens architecture that can be readily customized to improve color perception of persons whose health, emotions, and careers are negatively impacted by a prevalent form of red-green colorblindness. Taking a cue from reflective, sub-micron spaced lamellae in eyes of elephantfish, we hypothesize that optical nodes spaced at a lens surface can be customized to act as a notch filter to improve distinction of contrast and intensity in red and green hues. Eight undergraduates will be mentored in research, publication, and proposal preparation as they conduct collaborative simulation, custom design, fabrication, and measurements to validate personalized improvements in red-green color perception based on advances in simulation and fabrication in the PI’s lab.